High-dimensional unsupervised learning, with applications to genomics

PROJECT SUMMARY. This project involves the development of statistical methodology for the analysis of large- scale genomic data, such as gene expression, DNA copy number, and DNA sequencing data. In genomic studies, the goal is often to identify signal in the data in an unsupervised way. For instance, given the gene expression measurements for a set of patients with lung cancer, one might wish to discover previously unknown lung cancer subtypes that are characterized by distinct gene expression signatures and that might differ with respect to prognosis or response to therapy. However, the search for signal in genomic data is made difficult by the fact that the number of variables (e.g. genes) is generally orders of magnitude greater than the number of observations (e.g. lung cancer patients). As a result, principled methods must be developed to discover signal without overfitting. Furthermore, there is a need for objective ways to assess the validity of results obtained. This proposal has four specific aims, each of which involves the development of a new statistical method for solving a problem that arises in the analysis of genomic data. Aim 1: A method to learn multiple related genomic networks at once. For instance, one might expect that the gene expression networks for cancer and normal tissues will look similar to each other, with certain specific differences. The current proposal will provide a way to learn both networks simultaneously, in order to identify gene pathways that are perturbed in cancer. The proposed approach involves applying shrinkage penalties to the Gaussian graphical model formulation for network estimation. Aim 2: A principled approach for simultaneously clustering the rows and columns of a data matrix (e.g. patients and genes). The standard approach for discovering signal in genomic data involves clustering rows and columns independently, but the proposed approach will have increased power to discover biologically relevant clusters. The proposed approach involves applying shrinkage penalties to the matrix-variate normal distribution. Aim 3: A tool for the integrative analysis of multiple genomic data types collected on a single set of patient samples. For instance, if gene expression data, copy number data, and methylation data are collected for a single set of samples, then this will allow for the discovery of subsets of patients that are characterized by particular signatures of gene expression, copy number variation, and methylation. This could lead to the discovery of clinically relevant subtypes of cancer and other diseases. The proposed approach is an extension of the approach described in Aim 2. Aim 4: A flexible framework for the validation of clusters discovered in structured genomic data, such as DNA copy number and single nucleotide polymorphism data, in order to determine whether clusters discovered reflect signal or simply noise. The proposed approach is related to cross-validation, and will be extended to develop a method for the validation of other unsupervised statistical tools, such as those described in Aims 1-3 above. The statistical tools that result from the proposed research will be implemented in freely available software.

Public health relevance
Project Narrative A major goal of research in genomics is the development of personalized medicine - treatments for cancer and other diseases that are tailored to an individual based on his or her DNA sequence or other genetic information. Though some advances towards this goal have been made, overall progress has been disappointingly slow due to the difficulty in mining through extremely large genomic data sets in order to discover disease-related information. This project addresses this difficulty via the development of new statistical methods for making sense of genomic data. __SpecificAimsTextDelimiter__ SPECIFIC AIMS. Statistical methods can be divided into two categories, supervised and unsupervised. Supervised methods, such as classification and regression, involve predicting an outcome such as tumor subtype or survival time on the basis of a data set. Unsupervised methods, such as clustering and principal components analysis, seek signal in a data set in the absence of auxiliary information such as tumor subtype or survival time. While supervised learning is relatively well understood, unsupervised learning is a difficult statistical problem as it is easy to perceive signal when none is present and therefore to draw erroneous conclusions. Unsupervised learning on the basis of genomic data is particularly challenging since the data usually are high-dimensional - there are many more variables (e.g. genes) than observations (e.g. tumor samples). In recent years, massive amounts of genomic data have been collected, but biological discovery on the basis of these data has been hampered by a lack of effective statistical tools. As the goals of many genomic studies move away from hypothesis testing and towards hypothesis generation, unsupervised methods are of growing importance. Therefore, there is a need for the development of principled statistical tools that can be used to generate testable biological hypotheses on the basis of genomic data. Towards this goal, I propose these aims: Aim 1: Joint network learning. A network based on a genomic data set is an undirected graph, in which each vari- able in the data set is depicted as a node, and each pair of dependent variables is depicted as an edge between two nodes. I propose an approach for joint network learning, a tool for learning multiple genomic networks simultane- ously from related data sets (e.g. gene expression measurements on a set of normal patients, and a set of diseased patients). Rather than learning the network for each data set separately, I will develop a more powerful approach by making use of the fact that I expect many aspects of the networks to be shared. I will scale the proposed approach to large genomic data sets and will develop a concept of the false discovery rate for the estimated networks. I will then apply this approach to a collaborator's data set consisting of RNA sequencing data for 17 distinct cancer types, to discover gene pathways that are perturbed in cancer. Aim 2: A systematic approach to biclustering. I propose an approach for biclustering, a technique for clustering the rows and the columns of a data matrix simultaneously in order to increase power to discover signal. Existing approaches for biclustering have been somewhat ad hoc, and so the results obtained can be difficult to understand and validate. I will instead extend a little-known statistical model in order to perform biclustering in a rigorous way, using shrinkage approaches taken from supervised learning. I will apply this new approach to a collaborator's stem cell gene expression data set in order to discover distinct stem cell populations that are characterized by the expression of particular genes that are relevant to stem cell biology. Aim 3: Integrative analysis of multiple genomic data types. I will develop a new tool for performing an integrative analysis of multiple genomic data types (e.g. gene expression and DNA copy number assays) collected on a single set of patient samples. My multiclustering approach is based largely upon the technology developed in Aim 2, and will result in the discovery of sets of patients with distinct genomic signatures across multiple genomic assays. I will first determine how best to apply this method to large-scale genomic data, in terms of how to standardize the data types, whether to regularize estimation of the relevant parameters, and how best to select tuning parameters. I will then apply this method to a data set consisting of DNA copy number and gene expression measurements for patients with glioblastoma multiforme, in order to discover robust subtypes of the disease that are defined on the basis of both genomic data types. I will also apply it to data sets with copy number and expression measurements for patients with breast cancer, and with leiomyosarcoma. Aim 4: Validation of results from unsupervised learning. It is often difficult to determine whether an unsu- pervised method has discovered signal or simply noise. I will explore a new approach for validating unsupervised learning results by recasting the unsupervised problem as a supervised problem so that cross-validation can be applied. I will "leave out" elements of the data matrix at random, and will use the results of the unsupervised tech- nique applied to the remaining data to impute those left-out elements. The accuracy of this imputation can be used to assess whether the unsupervised learning technique has discovered signal in the data. I will first investigate the optimal strategy for leaving out elements. I will then study the performance of my proposal in validating clusters in structured genomic data - data characterized by strong patterns among the variables, such as DNA copy number data - for which existing cluster validation techniques fail. Finally, I will extend this approach to validate results obtained from other unsupervised methods, such as those developed in Aims 1-3. In addition, I will develop and release free R packages, Excel plug-ins, and/or GenePattern modules implementing the statistical tools developed in these aims.